COMPOUND PARABOLIC CONCENTRATOR PROBE FOR OPTICAL SPECTROSCOPY

Optical fibers used to transmit the light from the source to the spectrograph have an acceptance solid angle much less than that of the source such as tissue which spans a full 2p radians. Due to this much of the source light is not collected by the fiber. By using a non imgaging device as in compound parabolic concentrator (CPC), we have demonstrated that the light collected is 7 times more intense than that of would be collected without the CPC. This principle of using non-imaging device will have strong implication in tissue spectroscopy.